ADMINISTRATIVE CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Biomedical Research Center infrastructure is inherently complex and is comprised of administrative, mentoring, educational, resource, and research components. The goals of the Administrative Core are (1) to evaluate the effectiveness of center programs and cores, (2) to monitor the progress of individual research subprojects, (3) to administer the small grants program, (4) to ensure that all center programs, core components, initiatives, policies and reporting mechanisms are developed, implemented, and administered within federal granting agency policies and deadlines, (5) to provide fiscal oversight of all subprojects and cores, and (6) to provide high-level program and administrative support to Subproject PIs and Core Directors.